Does Dopamine Mediate Effects of Stress on Inhibitory Control and Smoking Lapse?

Project Summary/Abstract
Impact: Addiction to cigarettes costs society $138 Billion yearly in health care consequences and lost
productivity. It is very hard to quit – even for smokers who try. Conditions that make it harder for smokers to
resist smoking could trigger relapse. One potential culprit is stress - which comes in many forms. But how
does stress affect the brain and lead to relapse?
Goals: The long-term objective of this multi-modality investigation of the links between acute stress,
dopamine (DA) transmission and inhibitory control is to identify targets for therapy that will neutralize the
sequela of stress and thereby prevent relapse of drug use. In the current project, we will study smokers who
have been abstinent overnight to explore how a stressor may cause them to resume smoking. The immediate
objective of the proposal is to test the hypothesis that striatal DA transmission mediates (serves as a link
between) effects of biological stress on inhibitory control leading to relapse.
Innovation: We will use a biological model of acute stress in humans, a single low dose of endotoxin
(lipopolysaccharide(LPS)). For a short period, this stressor reliably elevates various markers of inflammation
such as TNFα as well as sickness symptoms (e.g., muscle pain) and mild mood changes. We were the first to
demonstrate with imaging that LPS triggers a cellular immune response in humans – marked by activated
microglia – as well as alterations in brain metabolism. In addition, our group has introduced and validated a
human laboratory model of smoking lapse behavior. We were the first to show that stress hastens
reinstatement of cigarette smoking in a controlled lab environment. This project will combine both models as
well as functional imaging with PET and fMRI to probe relevant neurochemistry and inhibitory circuitry.
Preliminary Findings: Recently, using PET imaging, we showed that acute endotoxin enhances DA
transmission in the dorsal striatum. In the human lab, we have found that LPS impairs cognitive control
(essential in resisting drug relapse).These novel findings open the door to a mechanistic explanation of the
connection between stress and reinstatement of drug use.
Approach: We will conduct three main experiments on a cohort of male and female smokers. Experiment #1:
Using PET, we will examine the effects of our stress model on DA transmission in smokers. Experiment #2:
Using fMRI, we will examine the effects of our stress model on response inhibition. Experiment #3: Using our
human lab paradigm, we will measure the effects of our stress model directly on smoking lapse behavior. By
combing results from our three experiments, we will determine if (a) stress affects DA signaling and response
inhibition in smokers, (b) DA mediates the effect of stress on disinhibition, and (c) if disinhibition predicts
smoking lapse behavior.

Public health relevance
Project Narrative Stress may cause abstinent smokers to relapse. Using brain imaging and behavioral tests, we seek to identify biological pathways in the brain that link stress to loss of inhibition and ultimately to resumption of cigarette smoking. The project will promote better understanding of how stress and neuroinflammation lead to drug use and the results may inform more comprehensive approaches to treatment.